Delineating the neural computational network for object recognition

Project Summary/Abstract
A core function of the human brain is object recognition, which underlies many higher-order functions like memory
and emotion. Deficits in recognizing objects are associated with various neurological disorders, such as visual
agnosia, schizophrenia, and Alzheimer’s disease. However, the neural mechanisms for object recognition remain
elusive. Specifically, little is known about how the brain translates visual inputs of objects into meaningful
semantics. Previous studies have proposed a hierarchical neural network for object processing, critically
including the visual temporal cortex (VTC) and the downstream medial temporal lobe (MTL). While recent single-
neuron studies in non-human primates evidenced an axis-based visual feature encoding in the VTC, human MTL
neurons have long been characterized to carry a sparse and selective code for individual exemplars (exemplar-
based coding). Yet the process by which visual feature representations in the VTC are transformed into semantic
representations of abstract labels in the MTL remains unknown.
This project aims to address this question by examining the neural computations and dynamics within the VTC-
MTL neural network during object recognition. We will utilize intracranial recordings at both individual neuron and
neural-circuit levels across different brain areas, coupled with sophisticated computational algorithms. Three
distinct neural coding models will be surveyed across the VTC and MTL, including the axis-based feature model,
the exemplar-based model, and the region-based feature model (a novel model proposed in our recent studies;
K99 AIM 1). VTC-MTL interactions and dynamics that are critical to object recognition will be identified (K99 and
R00 AIM 2). The derived results and analysis pipeline from the K99 phase will then be utilized to investigate how
different neural models transition from one to another along the VTC-MTL pathway to achieve the representation
transformation (R00 phase). The central hypothesis is that different coding models are employed at different
stages of object processing, and the novel region-based feature coding serves as an intermediate step that
bridges the axis-based coding in the VTC and the exemplar-based coding in the MTL.
This proposal will be conducted at Washington University in St. Louis (WUSTL), a top-rank research university
that offers excellent scientific support and career training. A team of established mentors will provide necessary
training in: iEEG data recording and analysis (Drs. Brunner and Willie), inter-areal interaction analyses (Dr.
Rutishauser), neural networks and cognitive neuroscience more broadly (Dr. Hershey), computational modeling
and statistics (Dr. Wang), and career development (all mentors). While the primary aims of this proposal is to
provide new insights into object recognition in humans across multiple scales, the anticipated outcomes have
the potential to inspire new therapeutic interventions for disorders involving impaired object recognition. This K99
award will critically facilitate the success of the proposed research and the applicant’s transition to independence.
1

Public health relevance
Project Narrative Object recognition lies at the heart of our ability to make sense of the visual world, engaging a series of hierarchical processing in the ventral temporal cortex (VTC) and medial temporal lobe (MTL) network, which coordinately transforms the visual inputs to semantic representation. This project aims to reveal the underlying neural computations and circuit-level dynamics during this process using human intracranial recordings at both single-neuron and neural-circuit levels, behavioral measurements, and sophisticated computational algorithms. The anticipated outcomes of this proposal will contribute to the mechanistic understanding of object perception, which will shed light on developing new therapeutic interventions for patients affected by object recognition difficulties .